Improving response prediction to neoadjuvant therapy in pancreatic cancer

PROJECT SUMMARY
Localized pancreatic cancers (PC) are rising in incidence and this trend is expected to continue due to increased use of
imaging modalities and focused programs on early cancer detection. Although potentially curable, long terms outcomes for
localized PC remain poor. This is due to early micrometastatic spread and risk of systemic recurrence which has been
reduced with use of systemic chemotherapy. In addition, use of chemotherapy prior to surgery lowers rates of positive
margins and these collective observations have led to the adoption of neoadjuvant chemotherapy (NAC), i.e. prior to surgical
resection, for majority of patients. NAC extends for multiple months (4-6 months) making real time assessment of response
critical. However, this remains a big clinical challenge as pancreatic tumors don’t change much in size with NAC and use
of tumor markers is marred by lack of specificity. Pathologic response to NAC on surgical resection specimens is highly
prognostic, yet its molecular predictors remain poorly understood. Transcriptional subtypes of PC include classical and
basal subtypes; the latter resembles triple negative breast cancer, displays chemotherapy resistance, and is enriched in
metastatic disease. Single cell analysis of pancreatic tumors reveals extensive heterogeneity between classical and basal
subtypes as well cells with co-expression of both features. In Aim 1, we use our institutional cohort of 174 patients who
underwent pancreatic tumor resection after receiving NAC to identify predictors of pathologic treatment response using pre-
treatment tumor specimens. We will investigate the classico-basal cell state heterogeneity using a validated multiplex
immunofluorescence panel on initial diagnostic biopsies to understand differences in cell state between tumors which exhibit
major response vs. no pathologic response. To identify novel predictive transcriptional states beyond classical-basal
subtyping we will perform digital spatial profiling using the Nanostring GeoMx platform. In Aim 2, we propose
investigating the utility of highly sensitive ctDNA assays to track changes in tumor burden and cell state during NAC. We
expect differential ctDNA dynamics during NAC to predict outcomes. In addition using novel ctDNA based epigenetic
assays we will assess whether tumoral cell state evolves during emergence of therapeutic resistance to more basal type. This
work will lead to identification of novel predictive biomarkers which can help physicians identify high risk cases which are
unlikely to respond to traditional NAC or identify early treatment resistance in real time and facilitate earlier switch to
alternative chemotherapy or consideration of clinical trials leading to an improvement in outcomes for patients with
localized PC. The proposed research will be performed at Dana-Farber Cancer Institute, under the guidance of Drs. Brian
Wolpin and Andrew Aguirre. Both are recognized international leaders in PC biology. Importantly, this research strategy is
one part of a comprehensive training program to support my transition to an independent research career in translational
cancer biology. My scientific advisors (Drs. Myles Brown, Ryan Corcoran, and Eliezer Van Allen) are distinguished experts
with experience highly relevant to the proposed research. My long-term goal is to lead an independent academic research
group, focused on deciphering the novel biomarkers and mechanisms underlying therapy resistance in PC. The K08 award
will provide pivotal protected time for continued mentored research and enable a successful transition to independence.

Public health relevance
PROJECT NARRATIVE Localized pancreatic cancers (PC) have a high risk of recurrence and are treated with neoadjuvant chemotherapy which improves cure rates though identifying early resistance during NAC remains a clinical challenge. This project utilizes advances in single cell transcriptomics, highly multiplexed imaging and ctDNA technologies, paired with large clinically annotated PC biospecimen repositories to develop methods for assessing response and identifying resistance to neoadjuvant therapies used in localized PC. I anticipate that this work will nominate novel biomarkers for clinical use.